Defining the role of TRIM proteins in vector-borne bunyavirus infection

Project Summary/Abstract
Bunyaviruses are a large group of RNA viruses that can cause severe disease in humans worldwide. Currently,
there are no specific antiviral treatments for any bunyaviruses. As the first line of defense against invading viral
pathogens, host innate immune system plays an important role in sensing viral infection and inducing type I
interferons (IFNs) and interferon-stimulated genes (ISGs). Many ISGs have antiviral activities and block viral
infection at different steps in the virus life cycle. IFN response plays a critical role in the control of bunyaviral
infection. However, the mechanisms by which host innate immune system restrict bunyavirus infection are poorly
understood. Tripartite motif (TRIM) proteins are a family of more than 70 members in human that play important
roles in the antiviral immunity by either regulating innate immune sensing pathways or directly suppressing viral
infection as antiviral ISGs. However, only a small portion of these proteins have been characterized functionally
and the contribution of TRIM proteins to the host defense against bunyaviruses remains to be elucidated. We
hypothesize that TRIM proteins play regulatory roles in the control of host innate immune response against
bunyaviruses. Therefore, using Rift Valley fever virus (RVFV) and La Crosse virus (LACV) as examples, this
proposal will characterize the role of TRIM proteins in the host innate antiviral immunity to vector-borne
bunyavirus infection. To achieve these goals, our specific aims will (1) characterize the TRIM proteins that
regulate bunyavirus infection and (2) define the antiviral action and the molecular determinants of one antiviral
TRIM protein we have identified. The results from these studies will advance our understanding of virus-host
interactions and could provide valuable information for the development of novel antiviral therapeutics.

Public health relevance
Project Narrative Bunyaviruses are distributed globally and can cause significant diseases in humans and animals, posing a significant threat to public health. Currently, there are no specific antiviral therapies available for any bunyavirus infections. This project will uncover the functional role of TRIM proteins in bunyavirus infection and aid the development of new strategies to control viral infection.